REGULATORS OF EPIDERMAL GENE EXPRESSION

REGULATORS OF EPIDERAL GENE EXPRESSION
PROJECT SUMMARY
DNA motifs bind transcription factors (TFs) that control gene expression in normal and diseased skin.
AR45192 recently mapped the enhancers and promoters that are sequentially activated during
epidermal differentiation, and found them enriched for 15 conserved DNA motif combinations, or DNA
motif “grammars”. This suggested that these grammars, acting through recruitment of motif-binding
TFs, may encode the DNA sequence logic that coordinates the temporal and spatial induction of early
and late epidermal differentiation genes. AR45192 also found that these grammars were recurrently
altered by single nucleotide polymorphisms (eSNPs, for “expression SNPs”) linked by genome-wide
association studies (GWAS) to skin diseases characterized by disrupted epidermal differentiation,
including cutaneous squamous cell carcinoma (SCC). This suggests that newly identified DNA motif
grammars may control differentiation and that their disruption may contribute to disease pathogenesis.
Aim I will test the hypothesis that specific DNA motif grammars control the physiologic activation of
differentiation genes necessary for normal epidermal function. First, it will define the temporal activity of
hundreds of examples of each grammar in early and late differentiation within intact epidermis. Second,
it will quantitate epidermal differentiation gene expression and barrier function in isogenic epidermal
tissues in which a subset of grammars have been altered by gene-editing. Aim I is designed to
characterize the actions of newly identified DNA motif grammars in epidermal differentiation.
Aim II will test the hypothesis that SCC risk eSNPs residing within epidermal differentiation motif
grammars alter gene expression in a way that enhances cancer progression. First, it will define SCC
eSNP impacts on gene expression in normal epidermis with a goal to understanding the altered target
genes, and their biologic functions, that predispose to SCC risk. Second, it will quantitatively assess the
impact of these SCC risk eSNPs, singly and in combination, on neoplastic progression of epidermal
neoplasia in vivo. Aim II is designed to define the impact of regulatory DNA variants on epidermal gene
expression and disease progression.
This AR45192 competing renewal will characterize the role of newly identified regulatory DNA
grammars in epidermal homeostasis and neoplastic progression.
RELEVANCE
Abnormal differentiation is a hallmark of common skin diseases, such as epidermal cancers,
psoriasis, atopic dermatitis, and certain ichthyoses. Transcription factors (TFs) bind DNA motifs in
enhancers to control differentiation gene expression in skin and other tissues. Characterizing the
patterns of normal and disease-linked DNA sequence motifs that control epidermal differentiation
may be of broad utility in the future treatment and prevention of skin disorders.

Public health relevance
REGULATORS OF EPIDERAL GENE EXPRESSION Project Narrative The control of gene expression determines the health or disease of human tissues, including skin. Systematic definition of the regulatory DNA motif combinations in homeostasis and early cancer progression is designed to provide information to advance human health for skin and other tissues. 1